CHARACTERIZATION OF ALPHA2 RECEPTORS IN SUBLINGUAL GLANDS

Dr. Santiago has completed laboratory rotations with Dr. Patricia M. Hinkle (Professor of Pharmacology), Dr. John E. Casnelli (Associate Professor of Pharmacology), and Dr. David J. Culp (Associate Professor of Dental Research and of Biochemistry; Assistant Professor of Pharmacology). Dr. Santiago has recently chosen the laboratory of Dr. Culp for his thesis project. His research interest is focusing on the characterization and cloning of alpha2 receptors in sublingual glands.